Compromised function of a glial glucose transporter in aging and Alzheimer's disease

SUMMARY
Aging is the most powerful risk factor for Alzheimer’s disease (AD), and it contributes to the odds of type-2
diabetes mellitus (T2D) as well. Aging is also associated with a decline in the brain’s use of glucose, its most
important fuel. Astrocytes play a key role in shuttling glucose from the bloodstream to where it is needed by the
neuronal units of activity deeper in the brain tissue. We find evidence of a defect in a key glucose transport
molecule of astrocytes in AD and in male mice of a line genetically modified to reproduce some aspects of AD.
Though the females also overproducing the β-amyloid peptide (Aβ), only males exhibit dysregulation of
circulating glucose, a decline in brain glucose usage, and spatial memory deficits. Human females have a
higher incidence of AD, but this is manifest after menopause, which mice do not experience. This suggests that
the female mice may be protected by sex-specific hormones such as estrogens. This supplement will test this
hypothesis by examination of female Aꞵ-expressing mice that have had their ovaries removed, and the role of
estrogen will be determined by adding this hormone back to some of the females. Peripheral glucose
regulation, brain glucose usage, and memory behavior will be tested to determine if loss of estrogens puts the
female mice at risk the same deficits seen in males. Because differences in the gene for apolipoprotein E
(ApoE) affect the risk for AD in a sex-dependent way, we will also assay the parameters above in mice that
have been genetically engineered to express two variants of human ApoE. These studies thus explore a novel
hypothesis about a specific element of energy utilization as it pertains to the aging brain and its connection to
sex-related risks. As such, the project may provide innovative strategies for therapeutic intervention.

Public health relevance
Narrative This project focuses on links between glucose metabolism and age-related neurological deficits that differ between males and females in both humans and experimental mice. The planned studies in mice will test the idea that problems with glucose delivery and utilization in the brain affect mental function and arise more often in women who have lost the sex hormones which decline after menopause. Similarly, a genetic difference that alters one’s likelihood of developing Alzheimer’s disease will be examined across male and female mice. Together, these studies may provide clues about the ways glucose regulation is perturbed in age-related brain disorders and why women are more vulnerable than men.